Ribosome Quality Control Mechanisms in Gram-Positive Bacteria

Project Summary:
Although bacterial ribosomes have been biochemically interrogated for decades, unknown mechanisms of
regulation and quality control are regularly uncovered and targeted with new antibiotics. Major differences in
translation between Gram-negative and Gram-positive organisms have come to light in recent years. Although
approximately half of antibiotic-resistant infections are caused by Gram-positive bacteria, major gaps remain in
our understanding of how Gram-positives perform ribosome quality control. To address these gaps, my
laboratory will focus on two major research areas. 1) We will identify and characterize strategies used by Gram-
positive bacteria to detect and rescue stalled ribosomes. Preliminary data from my lab supports a model in which
ribosome stalling in B. subtilis and B. anthracis results in frameshifting and premature translation termination.
This process is expected to result in toxic truncated proteins and trigger stress responses. We will test this model
using biochemical, genetic, and structural approaches. 2) We will determine how ribosome flexibility can be used
by the bacterial cell to expand coding capacity. Here, we will investigate how frameshifting and read-through of
poorly terminating UAG stop-codons regulates gene expression and identify environmental inputs for this type
of regulation. We will use biochemical, structural, and computational approaches to investigate the research
themes described above. To further expand this research program, we will use unbiased high throughput
genetics to uncover new mechanisms that prevent stalling and that regulate frameshifting and stop codon read-
through.

Public health relevance
Project Narrative: The goal of my research program is to investigate mechanisms by which Gram-positive bacteria maintain translation fidelity and efficiency. We will determine how ribosome stalling impacts cellular physiology and the structural integrity of the ribosome, and how protein synthesis can be regulated by atypical translation events such as frameshifting and stop codon read-through. Knowledge gained from these studies will increase our understanding of essential ribosome rescue pathways and uncover new antibiotic targets.